RFA-CE-22-004, Developing and evaluating an extreme risk protection order implementation protocol with impacted communities

PROJECT ABSTRACT
Firearm violence is associated with access to firearms at both the individual and ecological levels.
Preventing firearm access by those at significant risk of violence is a logical strategy to reduce firearm
homicide, firearm suicide, and nonfatal firearm violence. Extreme Risk Protection Order (ERPO) laws provide a
civil court option for temporarily removing firearms from, and preventing purchase by, high-risk individuals. To
date there are no empirically developed guidelines on how law enforcement agencies are to implement ERPO,
including firearm removal from newly prohibited individuals. This project will develop ERPO implementation
guidelines through the use of community-based participatory research with a focus on communities that
experience high rates of firearm violence. The research will unfold through a process that will be responsive to
feedback about ERPO from impacted communities about the need for ERPO implementation processes that
recognize the fractured relationships between their communities and law enforcement, and are trained on how
to constructively interact with people experiencing mental illness or a suicidal crisis. We will develop an
implementation strategy for implementing ERPO in a just and equitable manner. Our aims are as follows:
1. Identify counties in Florida and Maryland where ERPO use is high and describe how ERPO is being
used in those counties.
2. Document, understand, and examine the perspectives of impacted communities, prior respondents to
ERPO, and implementers about ERPO and its implementation.
3. Develop an Implementation Strategy for Impacted Communities centering on just and equitable
implementation of ERPO.
4. Pilot the ERPO Implementation Strategy for Impacted Communities and measure the acceptability,
feasibility, and sustainability of the Strategy among implementing stakeholders.
5. Revise and disseminate the implementation guide to interested stakeholders around the United States.
This project is responsive to the CDC’s RFA-CE-22-004 under Funding Option B. We will address Objective
One: Research to improve understanding of firearm injury and inform the development of innovative and
promising prevention strategies. An accomplished group of gun violence prevention researchers—including
national leaders in the field and those on the front lines of providing information and technical assistance to
policymakers and actors in the ERPO process—has come together for this innovative and timely research.
This project’s use of community-based participatory research and a framework of just and equitable ERPO
implementation will be invaluable to jurisdictions as they seek to implement this firearm violence reduction tool.

Public health relevance
PROJECT NARRATIVE The proposed project will unfold though a community-based participatory research process that will be responsive to feedback from impacted communities about how Extreme Risk Protection Orders (ERPOs) are implemented and the need for ERPO implementation processes that recognize the fractured relationships between impacted communities and law enforcement. We will develop an implementation strategy for agencies and organizations to use to implement ERPO in a just and equitable manner.